Assessing the role of lymphatic endothelial cell niche in intestinal regeneration

PROJECT SUMMARY
Endothelial cells that line blood and lymphatic vessels are abundant in the small intestine niche. Interestingly, in
the last decade, several groups have shown that endothelial cells have a role beyond “plumbing” and secrete
paracrine factors supporting the stem cell maintenance and regeneration of various tissues. Although ISCs
renew rapidly and continuously to sustain metabolic health, the role of lymphatic endothelial cells (LECs) in the
ISC niche is not well-established. Notably, LECs are known to express high levels of Rspo3, one of the WNT
signaling molecules required in the niche for ISC self-renewal. In my work, I have further made the observation
that the WNT modulator Wls is also highly expressed by LECs in the small intestine. In addition to putative roles
in homeostatic turnover, several lines of evidence suggest that endothelial cells become activated in response
to intestinal injury to drive epithelial recovery. Despite this knowledge, whether LEC derived WNT signaling in
the intestinal niche is essential for ISC regeneration after cytotoxic injury remains unknown. Based on this
premise, I aim to study the role of LECs in a model of chemotherapy-induced intestinal injury, a frequent and
devastating inflammatory condition that affects cancer patients.
The overarching goal of my project is to understand how endothelial cells contribute to ISC regeneration and I
propose that, in part, this is achieved through secretion of the WNT modulators RSPO3 and WLS by LECs. For
this reason, I have generated crosses to obtain mouse models in which either Rspo3 or Wls are selectively
knocked out from LECs in adult mice. My preliminary data indicate that in mice where Rspo3 has been deleted
from LECs in adult mice, there is a delayed recovery of ISCs after 5FU injury. I plan to further corroborate these
results in mice where Wls is deleted from LECs. Additionally, I will generate single cell RNA sequencing data to
determine transcriptional changes in crypt epithelial cells after 5FU injury in mice where Rspo3 has been knocked
out from LECs. Lastly, I will dissect changes in LECs as they relate to epithelial repair after 5FU injury. Together,
the proposed studies will define how signals from the lymphatic niche contribute to ISC regeneration and more
broadly will identify a potential novel intestinal niche component that can be therapeutically targeted to stimulate
intestinal repair.

Public health relevance
PROJECT NARRATIVE Endothelial cells are known to aid in stem cell maintenance and regeneration in many tissues, but little is known about the role of endothelial cells, particularly lymphatic endothelial cells in the intestinal niche. Additionally, how lymphatic endothelial cells in the small intestine change in chemotherapy induced mucositis and how these changes relate to epithelial repair, remains unknown. My proposed work aims to understand how lymphatic endothelial cells, in part through the expression of the WNT modulators RSPO3 and WLS, contribute to ISC regeneration after cytotoxic injury.